Seeds to STEM: Cultivating early Nutrition, Literacy, Numeracy, and STEM knowledge and skills in Teachers, 3-5 year olds, and Families through a Bilingual Asset-based curriculum in Two Major Cities

Seeds to STEM (S2S) proposes a bilingual program that educates urban children ages 3- 5, their families, and preschool teachers about the importance of childhood nutrition, early STEM and literacy, and kindergarten readiness in order to address national need to introduce all children to STEM at an early age and reduce rates of poverty, hunger, ill health, and low educational achievement among families living in dense cityscapes.”

Public health relevance
Seeds to STEM proposes a program that educates low- income children ages 3-5, their families, and preschool teachers about childhood nutrition, early STEM and literacy, and kindergarten readiness. It has an innovative focus on food access and serves populations in under-accredited early childhood care and learning centers, including home-based childcare providers. Seeds to STEM will be piloted in two major cities (Philadelphia, PA and Los Angeles, CA) and its three product deliverables will be distributed nationwide via a website and multiple professional dissemination networks.